Great Lakes Center for Fresh Waters and Human Health

The Great Lakes Center for Fresh Waters and Human Health (the Center) at the University of
Michigan (UM) is building on five years of successful interdisciplinary collaboration and
community engagement to further our understanding of the critical risk that cyanobacterial
harmful algal blooms (cHABs) pose to freshwater ecosystems and human health, which now
occur in all five Great Lakes. This Center, led by a multi-institutional team of biomedical scientists,
limnologists and community engagement experts with an extensive history of working together,
seeks to advance the work begun in Lake Erie, which has experienced the most severe cHAB
events in the last decade–including a 2014 episode that led to a complete shutdown of the
Toledo, OH, water supply. The Center’s four research projects will directly address
overarching themes prioritized by the COHH4 program. First, we will specifically resolve
dynamics of the development of blooms, production of toxins, and transport of those toxins
in the Great Lakes and in the atmosphere. Second, we will study toxins and mechanisms of
toxicity, including identification of emergent toxins and determination of health risks associated
with airborne and waterborne toxins. Third, we will develop new technologies for enhanced
monitoring and forecasting; we will collaborate with colleagues at NOAA and the Cooperative
Institute for Great Lakes Research (CIGLR) to integrate our findings into state-of-the-art forecasts
and other data products that reach a wide stakeholder audience. Fourth, we will leverage an
extensive network of community engagement vehicles in the Great Lakes, including the
Michigan and Ohio Sea Grants, public health departments, state and local agencies, the Great
Lakes Integrated Science Assessment (GLISA), and community science initiatives involving Lake
Erie Charter Boat captains and the U.S. Coast Guard. The Center’s Administrative Core is
focused on supporting and coordinating the four integrated research projects, a Community
Engagement Core, and a Facilities Core, to ensure progress toward the stated goals of
understanding and translating cHAB events and their threats to human health in the Great Lakes
region.

Public health relevance
By generating and disseminating data on health risks from HAB exposures, this Center will support evidence-based decision-making to protect public health. Led by a multi-institutional team of biomedical scientists, limnologists, and outreach professionals, the Center seeks to expand its work in Lake Erie by investigating how environmental stressors—such as storms, flooding, drought, and temperature variability—influence cHAB growth, toxin production, and the movement of these toxins through water and air. These efforts aim to inform strategies that assess and reduce health risks associated with cHAB exposure in affected communities.